Predoctoral Training in Addiction Science

Program Summary/Abstract
The present proposal is a continuation of an interdisciplinary, predoctoral training program in research on
substance use disorders (SUDs) currently in its 34th year as a NIDA-supported training grant. The objective
continues to be the preparation of individuals for careers that require broad knowledge and research expertise
in addiction science, with emphasis on drug and alcohol use disorders (alone or in combination), consistent with
the Collaborative Research on Addiction at NIH (CRAN). Only predoctoral trainees with an established interest
in pursuing research related to SUDs are selected from a substantial pool of competitive applicants at the
University of North Carolina, Chapel Hill (UNC-CH). The environment at UNC-CH provides optimal resources for
training in addiction science, including rapidly advancing 21st century methodologies. First, the training program
includes a core of faculty mentors whose research and teaching activities provide a broad spectrum of research
training opportunities. These include research programs focusing on motivated behaviors, opioid and cytokine
neurobiology, astrocytes in SUDs, the neuropharmacology and neurobiological effects of abused substances,
investigations of the immune system and of HIV/AIDS and SUDs, brain stimulation methods, pain/opioids,
behavioral genetics of SUDs and vulnerability and impulsivity. The inclusion of mentors from the Clinical
Psychology program and from UNC’s Obstetrics & Gynecology Department brings research opportunities in
translational areas that will enrich the trainees’ knowledge in SUDs treatment. Research laboratories are located
within the Psychology and Neuroscience department, the Psychiatry department, the Neurology department, the
Neuroscience Center and the Bowles Center for Alcohol Studies. Second, all trainees receive formal training in
basic neural and behavioral sciences and statistics. More focused training related to addiction science takes
place through several interdepartmental courses and seminars and extensive laboratory research. Third, the
program offers many opportunities for professional development through a yearlong Seminar in Addiction
Science which trainees take part in every year as they progress through the program. The Seminar in Addiction
Science provides a) training in grant writing, b) practice in making research presentations, c) numerous
presentations by outside scientists in addiction science and d) introduction of a range of career options. Fourth,
the trainees regularly present their research at national meetings and receive training in teaching skills. Finally,
UNC-CH is committed to maintaining ethical conduct in research and in methods for enhancing reproducibility
in science, and these topics are integrated from a variety of sources and takes place over the course of the entire
training period. Over the last 15 years, 37 trainees have received their PhD (average time to degree: 5.6 years)
and the program has successfully trained several individuals from underrepresented groups. Upon completion
of the program, trainees have established careers within addiction science, in both academic and research-
intensive settings.

Public health relevance
Project Narrative Substance use disorders remain a serious problem in this country. The interdisciplinary training program proposed here addresses that problem by preparing individuals with the skills necessary to advance knowledge of the behavioral, neurobiological and pharmacological effects of drug and alcohol use disorders. This knowledge is central to the development of treatments for those who are suffering from this illness and for the prevention of this disease in others.